Molecular Biophysics predoctoral training at The Ohio State University

Summary This proposal will establish a Molecular Biophysics Training Program (MBTP) at The Ohio State University. OSU has a strong group of researchers and attracts a strong student pool in molecular biophysics, but graduate training and research is fragmented over several graduate programs, departments, and colleges. The MBTP will bring these entities together and create an integrated training experience, in which students from three different graduate programs (Biophysics, Ohio State Biochemistry Program, and the Biological Division of Chemistry) and many different undergraduate backgrounds learn from each other and from a broad spectrum of mentors. As a result of MBTP, all trainees will obtain core training for breadth in macromolecular and physical biochemistry, in the fundamentals of biophysics, and in the responsible conduct of research to ensure that they can communicate equally well about today’s most challenging biomedical problems and about the modern quantitative and molecular methods to address these, while being responsible citizens and researchers. A broad spectrum of elective courses will ensure that students have enough depth to be successful in their research projects. The envisioned training combines the best the contributing graduate programs have to offer to provide a better and more coherent training experience in molecular biophysics than any of the three contributing programs offer by themselves. A monthly workshop series and a yearly symposium provide cohesion to the program and incorporate unique training opportunities such as alumni presentations on non­academic job choices, continuous engagement with ethics training, and discussion of best practices in graduate training. The resources invested into the program by NIH and matched by the institution will allow us to recruit and retain the strongest interdisciplinary students with greater inclusion of underrepresented groups. Guiding principles of excellence, collaboration and interdisciplinarity, and diversity and inclusion are used to build an organized plan for the best training, research and career development for students of molecular biophysics.

Public health relevance
Project Narrative We propose establishment of a Molecular Biophysics Training Program (MBTP) that leverages the research and training experience of 31 faculty Trainers in four colleges and ten departments to create a unique training experience at the crossroads of the quantitative, molecular, and biomedical sciences. Students from three different graduate programs and many different backgrounds will have the opportunity to interact with and learn from each other and from the many experienced Trainers. This training will prepare graduates to address the biomedical challenges of the twenty first century with truly collaborative and comprehensive approaches that address pressing needs in career development and inclusion of diverse groups.